Leveraging large datasets to determine genomic impact of transposable elements in Alzheimer’s Disease and related dementias

ABSTRACT
Alzheimer's disease (AD) is a complex neurodegenerative disorder with genetic and environmental factors
contributing to its development. Transposable elements (TEs) have been identified as prevalent in individual
neurons within the cerebral cortex, a region closely associated with AD progression. Recent research has
indicated a connection between AD-associated Tau protein and TE activity. A closer investigation is highly
demanded to explore the prevalence and relevance of TEs in AD and related dementias (ADRD), by overcoming
the repetitive nature of TEs and the constraint of small sample size in human studies. This proposal aims to
investigate the landscape of TEs in large cohorts and their association with AD and ADRD, further revealing the
functional impact of TE on AD and AD-related phenotypes. To achieve this, the project will leverage the extensive
datasets from large AD projects, which encompass genomic sequences and detailed clinical information. A novel
cloud-based infrastructure will be developed to overcome computational challenges and complexities involved
in the analysis of such large-scale datasets on the cloud server. The study will identify patterns of diagnostic
nucleotides within TEs using an adapted pipeline from large genomic consortia and reveal the potential functional
impact of AD-relevant TEs in the insertion loci. Furthermore, TE-derived expression profiles or TE transcript
abundance in different brain regions will be assessed using a tailored pipeline from RNA-seq data. Combining
the expression profiles from TEs and gene regions affected by TE insertions with clinical and neuropathological
metrics, we will develop a predictive model for dementia diagnoses. The project's deliveries and innovative
aspects include the landscape of TEs and their diagnostic nucleotide patterns in large AD and AD-related cohorts,
a novel and generalized cloud-based pipeline designed to efficiently package genetic variant calling process in
on-cloud large datasets, and a predictive model integrating TE-derived expression profiles and TE diagnostic
nucleotides with detailed clinical information for AD diagnosis. Through this project, we set the stage for a deeper
understanding of the genetic etiology of AD and ADRD and may open avenues for future studies on novel
therapeutic strategies and improved patient care.

Public health relevance
NARRATIVE Alzheimer's disease (AD) is a complex neurodegenerative disorder with genetic and environmental factors contributing to its development. This project seeks to explore the connection between one kind of repetitive sequences in the human genome, known as ‘jumping genes’ or transposable elements (TEs), and AD and related dementias, using innovative and interdisciplinary methods on a very large number of samples. By revealing the role of TEs in AD, the project holds the potential to contribute significantly to our understanding of this complex neurodegenerative disorder and may open avenues for new cures and improved patient care.